Systems Genetics Analysis of Sex Differences in Alzheimer's Disease

PROJECT SUMMARY
Our proposed research aims to identify sex-specific genetic drivers of neuropathologic, cognitive, and
metabolic phenotypes of Alzheimer’s disease by integrating longitudinal behavioral and molecular data from
AD mice with genetic, genomic and clinical data from human cohorts. We will leverage a newly generated
mouse population that incorporates high-risk familial AD (FAD) mutations on a genetically diverse background
(BXD panel) to identify modifiers that contribute to AD resilience in this ‘humanized’ mouse population. In
parallel, we will incorporate cutting-edge single-cell omic approachs to generate a molecular atlas of human
brains from carriers of FAD mutations (in APP, PSEN1 and PSEN2) and non-carriers with sporadic AD. By
combining and validating analyses in both mouse and human datasets, we expect to find molecular candidates
that robustly contribute to sex-specific variation in symptoms of AD. We will further validate these candidates
using unparalleled in vivo mouse technology to not only empircally assess their role in sex-specific
mechanisms of disease, but also to evaluate sex X genotype X treatment interactions in a subset of candidates
(i.e., Apoe) to inform more personalized therapeutic approaches. The approach we propose benefits from the
enhanced discovery power and value of existing human genetics resources and novel, precision AD mouse
models across multiple institutions to investigate the mechanisms of sex differences in AD.

Public health relevance
PROJECT NARRATIVE Women are disproportionately affected by Alzheimer’s disease, and there are well-documented—but poorly understood—sex differences in disease progression and response to therapeutics. Insights into the mechanisms underlying these sex differences will allow us to better treat AD, and improve individualized approaches to disease intervention. The work proposed here will utilize powerful mouse models of AD and rich, multilevel human datasets to identify genes and pathways that robustly regulate sex differences in the symptoms and response to treatment in AD.